Venous Thromboembolism Sequelae in a Population-based Inception Cohort

PROJECT SUMMARY / ABSTRACT
Nearly 1 million Americans each year experience a first venous thromboembolism (VTE), which includes deep
vein thrombosis (DVT) and pulmonary embolism (PE). VTE is typically viewed as an acute event that is
treatable by anticoagulants, with less focus on chronic adverse VTE sequelae or on rehabilitation. Adults who
have experienced an incident VTE may be at high risk for adverse VTE sequelae in the first 12 months after
their event, including patient-relevant symptoms (such as dyspnea, pain, and swelling) and adverse clinical
outcomes (VTE recurrence and death). Research to-date has characterized the post-thrombotic syndrome
occurring post-DVT, but there has been much less attention given to sequelae following an incident PE.
Furthermore, almost all research about sequelae after both DVT and PE has been in the context of
anticoagulation with vitamin K antagonists rather than with newer direct oral anticoagulants (DOACs), which
are now primarily used in practice. Clinically, we lack methods to identify adults at greatest risk of adverse VTE
sequelae and how to prevent these sequelae. Whether several promising biomarkers that are readily available
for clinical measurement (brain natriuretic peptide, D-dimer, and troponin), or, whether modifiable exposures
such as anticoagulant type or physical activity are associated with adverse VTE sequelae is incompletely
understood. In the proposed research, we will characterize patient-relevant symptoms and adverse clinical
outcomes at multiple timepoints in the first 12 months post-VTE and will evaluate biomarkers and modifiable
risk factors in relation to these VTE sequelae. To accomplish this, we will create a new prospective population-
based inception cohort study based in Kaiser Permanente Washington, an integrated healthcare delivery
system in Washington State. Our preliminary research supports the feasibility of daily identification of incident
VTE cases among adult enrollees, and we anticipate ~957 eligible adults with validated VTE across 33 months
of enrollment. De novo data collection in ~380 consenting adults will include: 1) surveys at 2 weeks and 1, 3, 6,
and 12 months post-VTE to collect information on post-VTE symptoms, 2) wrist-worn accelerometers to
objectively measure physical activity and resting heart rate in the 12 months post-VTE, and 3) blood collection
within 4 weeks of the incident VTE to measure 3 pre-specified biomarkers. These study data will be combined
with rich electronic health record data to accomplish 3 scientific aims: (1) Characterize the prevalence pattern
of symptoms at 2 weeks and 1, 3, 6, and 12 months post-incident VTE and clinical outcomes over the 12
months of follow-up; (2) evaluate the associations of key biomarker levels measured in blood collected within 4
weeks of the incident VTE; and, (3) evaluate modifiable risk factors for sequalae, including VTE anticoagulant
type and physical activity level. This research will fill critical knowledge gaps that are important to patients by
providing estimates of the prevalence of clinically burdensome VTE sequelae and identifying possible etiologic
and modifiable risk factors that can be targeted in future interventions.

Public health relevance
PROJECT NARRATIVE Clinically, we lack ways of identifying adults at high risk of adverse outcomes after a first venous thromboembolism, which is a blood clot in the veins including pulmonary embolism and deep vein thrombosis. Adults who have experienced a venous thromboembolism may be at high risk for patient-relevant symptoms, a second venous thromboembolism, and death. In this study, we will characterize adverse outcomes in the 12 months after a first venous thromboembolism and will evaluate whether 3 biomarkers and 2 modifiable risk factors (anticoagulant type and physical activity) are associated with these outcomes.